Genomics Core

GENOMICS CORE
Summary: The thematic research focus of the KBRIN program is “functional genomics”. This field of
study is relevant to all aspects of life, health, and behavior of humans based on their genetic make-up and
interactions with their individual environment. The study of genes, their gene products, and their mutual
interactions has become crucial for the development of therapies to combat human diseases, to understand
the etiology of such diseases, and to narrow in on personalized individual treatment options based on
genetic and genomic information of the patient. Thus, functional genomics technologies like those
implemented in the UofL Genomics Core will be increasingly essential for the health care of current and
future populations.
Innovative technologies like whole genome DNA and transcriptome RNA sequencing and massively
parallel gene expression profiling have become technically and economically feasible. However, the
infrastructure is best placed in centralized facilities because it is cost-prohibitive for individual research
laboratories. Thus, the instrumental and intellectual research infrastructure provided by the Core represents
a critical component for the future overall strategic purpose for biomedical research community in Kentucky,
with the potential for a positive state-wide impact for the development of competitive research. This core, its
equipment and its staff will serve the UofL and its research base, and will also serve the investigators in the
network-affiliated institutions in the KBRIN.